Thymic medullary epithelial cell turnover and control of immune tolerance

A normal and robust immune system relies on the development of a diverse repertoire of T cells that are tolerant of self-
tissues. The thymus is a critical site for the development and education of T cell to promote tolerance to self and thus
prevent autoimmune diseases, such as Type 1 diabetes or multiple sclerosis. Within the thymus, the Autoimmune Regulator
(Aire) gene is a key player in the maintenance of immune tolerance as evident by its identification as the defective gene in
the human autoimmune syndrome Autoimmune Polyglandular Syndrome Type 1. Aire acts within specialized medullary
thymic epithelial cells (mTECs) to promote the expression of hundreds of self-antigens for the purpose of removing
developing self-reactive T cells in a process known as negative selection. Recently however, we have uncovered new
populations of mTECs that develop from cells that formerly expressed Aire that we have termed post-Aire-expressing (post-
Aire) cells. These cells appear to fall into 2 subsets: (1) a keratinocyte-like cell that is associated with Hassall's corpuscles
and (2) a tuft-like cell similar to specialized intestinal tuft cells. These cells show distinct patterns of gene expression with
intermediate levels of self-antigen expression compared to conventional mTECs, suggesting that they may play a distinct
and complementary role in mediating T cell tolerance in the thymus. We have developed a powerful set of genetic tools and
mouse reporter lines that allows us to mark, follow and purify these unique cells in order to study their function in the thymus
and their contribution to immune tolerance. We hypothesize that post-Aire cells in the thymus represent a unique subset of
thymic epithelial cells that mediate the maturation and development of tolerogenic T cell populations. Therefore, we propose
to test this hypothesis through the following specific aims: (1) Define markers of cell identity and key pathways of cell
development in thymic tuft cells, (2) Examine the effect of post-Aire mTEC's on T cell selection and thymocyte development,
and (3) Assess the contributions of post-Aire mTECs to immune tolerance in vivo. These studies will allow us to uncover the
development and function of these novel cells within the thymus as well as their contribution to T cell selection and
maturation as well as induction of other important immune regulators, such as T regulatory and invariant natural killer cells.
In this way, we hope to understand the role of these cells in the promoting immune tolerance and how they may be
employed in the prevention of autoimmune disease.

Public health relevance
This project aims to understand the properties and function of a novel population of specialized cells within the thymus that are derived from cells that previously expressed Aire, a gene that is important in the prevention of autoimmunity. These post-Aire-expressing cells have unique features to that suggest they may further support maturation of T cells and induction of other important regulatory T cells. The proposed studies will define the important characteristics of these cells, how these cells develop, and how they may influence T cell development. The results of these studies will allow us to better understand how these cells may promote immune tolerance to self and prevent autoimmune diseases, such as Type 1 diabetes.